LOH at BRCA1/BRCA2 Loci in Mutation Carriers as a Precursor to Breast Tumorigenes

DESCRIPTION (provided by applicant): Women who carry mutations in the BRCA1 or BRCA2 tumor suppressor genes are at extreme risk for breast cancer. BRCA1 or BRCA2 mutation carriers are heterozygous, but their breast tumors typically show loss of heterozygosity (LOH), i.e., loss of the wild-type BRCA allele. LOH at the BRCA loci has been thought of as a rare event, occurring in single cells that are the proximate precursors of a tumor. Recent evidence suggests it may occur instead as earlier or more frequent events giving rise to a large population of cells poised for neoplastic transformation - a "field effect". This study will determine whether LOH at the BRCA loci is typically present in histologically normal or pre-neoplastic breast epithelia of mutation carriers. It is a first step in exploring the potential of LOH at the BRCA loci as a marker for diagnosis or prognosis in mutation carriers, and for new approaches to chemotherapy and chemoprevention that target the DNA repair defects of cells lacking BRCA1 or BRCA2 function. Specific aims will be: 1. To determine whether LOH at the BRCA loci is typically present in pre-neoplastic and histologically normal tissue outside the margins of breast tumors in mutation carriers. Samples of breast tissue will be micro-dissected and assayed by Pyrosequencing, a high-throughput, micro-sequencing technology for mutation detection and allele quantification. For each patient, an individualized Pyrosequencing assay at the mutation site will be designed for direct quantification of the mutant and wild-type alleles. 2. To determine whether LOH at the BRCA loci can be similarly detected in breast tissue removed in prophylactic mastectomy from BRCA mutation carriers, in advance of any diagnosis of breast cancer. 3. To test the feasibility of detecting LOH at the BRCA loci in breast biopsies of BRCA mutation carriers. PUBLIC HEALTH RELEVANCE: This project will study genetic (DNA) changes in women from certain families that are prone to breast cancer. Understanding how these changes take place in breast tissue may open new approaches to early diagnosis, treatment and prevention for this special, high-risk group of patients.

Public health relevance
PROJECT NARRATIVE This project will study genetic (DNA) changes in women from certain families that are prone to breast cancer. Understanding how these changes take place in breast tissue may open new approaches to early diagnosis, treatment and prevention for this special, high-risk group of patients.